Functional Biomarkers for ALS

Project Summary
Functional non-invasive biomarkers are critical for therapeutic target engagement outcomes in
progressive rare diseases. Amyotrophic lateral sclerosis (ALS) clinical trial development has an urgent need for
functional biomarkers to assess therapeutic response and target engagement. We will fulfill that urgent need.
We have a history using functional blood-based biomarkers for clinical trials in ALS. Rasagaline (a
neuroprotective compound) showed mitochondrial biomarker target -engagement in an open-labeled trial. A
subsequent multi-center placebo-controlled trial failed to replicate target engagement. Disparities among
clinical trial outcomes revealed issues with sample handling and the need for a generalized estimating
equation (GEE) statistical model. Without the ability to accurately detect target engagement therapeutic
opportunities will be lost.
ALS pathological features include mitochondrial dysfunction and loss of proteostasis (protein
aggregation). Mitochondrial dysfunction and proteostasis are intricately linked biological modalities which are
key targets for upcoming clinical trials in ALS. These clinical trials will benefit from our functional biomarkers.
We will clinically validate blood based mitochondrial and proteostasis biomarker protocols for use as indices of
target engagement in future clinical trials. We will compare mitochondrial and proteostasis biomarkers within
ALS and control subjects over eight months. We will develop a GEE statistical model to provide guidance for
power calculations in our future planned clinical trials. We will determine biomarker relationships and develop a
predictive statistical approach for our novel functional biomarkers.

Public health relevance
Project Narrative This project will yield blood based functional biomarkers for use in therapeutic clinical trials for amyotrophic lateral sclerosis (ALS). Clinical trial readiness for this rare disease requires clinically validated treatment response biomarkers. Our biomarkers are novel and will serve to measure treatment response and in upcoming therapeutic clinical trials.